Mechanisms sustaining lytic herpesviral infection in the oral cavity

Abstract
The oral epithelium is often the gateway for many different viruses into the human body. The oral cavity has a
complex multi-species microbiome, which includes bacteria, fungi, and viruses. The interaction between the
different microbiome elements and the bacterial secretions such as short-chain fatty acids (SCFAs) play a crucial
role in regulating oral infections, however, the underlying mechanisms are still largely unknown. Clinical studies
on periodontitis showed that the amount of oral bacteria (e.g., P. gingivalis) correlates with that of herpesviruses
including the human oncogenic DNA virus, Kaposi's sarcoma-associated herpesvirus (KSHV). The primary route
of KSHV infection in humans is through the oral cavity, which is the least understood step in KSHV infection. The
goal of our study is to determine the molecular mechanisms that control the infection of oral epithelial cells by
KSHV and how oral KSHV infection is affected by oral bacteria and their metabolites such as SCFAs. We found
that P. gingivalis and bacterial metabolites can increase the expression of stress response-related cellular
transcription factors in oral epithelial cells, and they are crucial for the robust herpesvirus infection of oral
epithelial cells. Based on our preliminary data, we hypothesize that the reason that the oral epithelial cells are
supportive of lytic KSHV infection is because they have unique cellular properties, which SCFAs can upregulate
resulting in enhanced KSHV infection. In Aim 1 of this proposal, we will investigate the mechanism by which
SCFA increases the protein level of stress response-related host transcription factors in oral epithelial cells and
how they promote KSHV infection. Aim 2 will focus on the identification of KSHV factors that can also induce
stress response-related host transcription factors, and their importance in the KSHV infection of oral epithelial
cells will be investigated. We envision that understanding of how the metabolites of oral bacteria support KSHV
infection in the oral epithelium will help to find targets that can be used for developing new therapeutic antivirals
to block oral infection not only by the cancer-causing virus KSHV but potentially by other human pathogens as
well.

Public health relevance
Narrative The oral microbiome has a profound but still poorly understood impact on the outcome of oral viral infections. This study focuses on investigating how bacterial metabolites and Kaposi's sarcoma-associated herpesvirus can induce the expression of stress response-related transcription factors in oral epithelial cells and how they can control the oral viral infection. We expect that our results can facilitate the future development of novel antiviral approaches that can inhibit not only KSHV but also other viral infections in the oral cavity eliminating oral viral transmissions.